Administrative Core

Montana INBRE Administrative Core Project Summary
The role of the MT INBRE Administrative Core (AC) is to assure that all institutions in the network and
Cores work together. By building connections among institutions, cores, faculty, and students, the AC will
maximize the impact of our program. Efforts will be guided by continual and thoughtful monitoring of program
activities with a goal of facilitating communication and building synergy. The AC is responsible for distributing
and managing MT INBRE V resources and establishing and maintaining partnerships as well as program
interactions with the External Advisory Committee (EAC), Steering Committee (SC), Executive Committee
(EC), Project Leaders, and Cores. As the organizational nexus, the AC will schedule meetings, select key
personnel, oversee research projects conducted within MT INBRE V, and conduct program evaluation. The
paramount responsibility of the AC is to ensure that MT INBRE V remains focused on the goals of the program,
which are to 1) diversify the biomedical/health sciences research network and student pipeline in Montana and
2) utilize this network to address the serious health concerns that face Montana’s rural and Native
communities. To realize these goals and accomplish MT INBRE V’s overall aims, the AC will achieve the
following Specific Aims: Specific Aim 1. Facilitate the MT INBRE V Leadership Team's ability to diversify, unify,
and improve Network inclusivity. Specific Aim 2. Provide transformative career opportunities for K-12,
undergraduate, and graduate students through research. Specific Aim 3. Support faculty recruitment and
career development through funding, training, and networking. Specific Aim 4. Enhance programmatic impact
using an evaluation, planning, and implementation cycle.
The MT INBRE network is culturally and economically diverse with most participating institutions located in
rural and tribal communities. Our overarching goal is to catalyze and strengthen the research culture at
network institutions, encourage research excellence, and provide students with research opportunities that
create a strong biomedical research workforce. The AC makes sure the program is fully integrated, inclusive,
equitable and fosters diverse perspectives.